Occupational Safety and Health Training and Education Grant

Current projections indicate a significant shortage of occupational health and safety professionals, including
industrial hygienists, because of an imbalance between the supply and demand of suitably trained and
educated professionals. Additionally, there is a disparity in the percentage of under-represented minority
professionals in the occupational safety and health fields. The Tulane University industrial hygiene training
program addresses these issues through its goal of providing support for industrial hygiene graduate students
in the School of Public Health & Tropical Medicine MSPH-IH degree program. The MSPH industrial hygiene
program began in 1980, a distance learning option was added in the early 1990s, and the program has been
ABET accredited since 1996 including both the traditional on-campus and the distance learning options.
Tulane also offers a graduate certificate in industrial hygiene and a PhD in environmental health science with a
focus on industrial hygiene. The Industrial Hygiene graduate program curriculum is comprehensive and
includes core courses from various public health disciplines and specialty courses in industrial hygiene.
Courses include epidemiology, biostatistics, toxicology and risk assessment, radiological health, industrial
ventilation and hazard control, physical agents, air sampling and analysis, occupational health, principles of
industrial hygiene, and industrial safety. In addition, practice experience, applied research thesis, and
comprehensive exam are required for completion of the degree. Since its inception, the program has
graduated 208 masters students, of whom 37 were under-represented minorities. Approximately one-third of
our alumni have obtained professional certification from the American Board of Industrial Hygiene. Current
program students are trained and mentored by three core industrial hygiene faculty with the support of a large
cadre of regular and adjunct faculty with expertise in related and ancillary disciplines including environmental
health, occupational medicine, environmental epidemiology and safety science. NIOSH funded traineeships for
Tulane MSPH-IH students began in 2005. In academic year 2020, 7 trainees are receiving support, 2 on
campus and 5 in distance learning. Two of our current trainees are minorities. Recruitment of minority students
into the Tulane program will be facilitated through continuing collaboration with Xavier University of Louisiana,
an HBCU. Of our 37 minority graduates, 19 received undergraduate degrees from Xavier. The Tulane training
program will continue to provide support for MSPH-IH students in on-campus and distance learning options.
Tuition/fee and stipend support will be provided for selected full-time on-campus students and tuition/fee
support provided for selected distance learning students. Support for trainee travel to professional conferences
for attendance or presentation will also be provided. The program target is to provide support for four to six
student trainees per academic year.

Public health relevance
Americans spend a major part of their adult lives in the workplace and increasingly, the adverse effects of workplace conditions, exposures, and stressors on workers' health are being recognized. This academic Training Program addresses this public health issue through our goal of training qualified masters-level industrial hygienists - front line professionals engaged in the primary prevention of occupational injury and illness - with a special focus on the recruiting of minority student trainees.